Epigenomic mechanisms of cardiac fibrosis and heart failure

PROJECT SUMMARY
A heart failure diagnosis leads to poor quality of life and a 5-year mortality nearing 50%, underscoring the urgent
need for innovative treatments. Clinical evidence strongly links myocardial fibrosis, driven by pathological
activation of cardiac fibroblasts, with unfavorable outcomes in heart failure patients. Prior efforts to control fibrosis
often targeted signaling pathways, integrins, or extracellular matrix components, affecting many tissues.
However, much less is known about the epigenomic mechanisms governing cardiac fibrosis and fibroblast
activation. Understanding these mechanisms could lead to more targeted therapies.
We previously showed that pharmacological inhibition of bromodomain and extra-terminal (BET) proteins, key
mediators of stress-activated chromatin signaling, alleviates cardiac dysfunction and fibrosis in mouse heart
failure models. Single-cell genomics demonstrated that BET inhibition suppresses fibroblast activation and
profibrotic gene programs. One of the most BET-sensitive genes, Meox1, is minimally expressed in healthy
hearts but highly upregulated in activated fibroblasts during heart failure. Single-cell transcriptomics also showed
significant MEOX1 upregulation in human heart failure. In fibroblasts treated with TGFβ, MEOX1 inhibition
reduced profibrotic functions and expression of stress-responsive gene programs. Notably, fibroblast-specific
Meox1 deletion in vivo in mice mitigates transverse aortic constriction (TAC)-induced cardiac dysfunction and
decreases fibroblast activation, highlighting MEOX1’s potential as a therapeutic target.
This proposal consists of two aims leveraging novel genetic mouse models, cell lines, and advanced
transcriptional, epigenomic, and computational approaches to test the overall hypothesis that MEOX1
functions as a key transcriptional regulator of fibroblast activation, fibrosis, and heart failure
pathogenesis. Aim 1 will examine the impact of fibroblast-specific Meox1 deletion on cardiac fibrosis and heart
failure in mice, with single-cell analysis revealing global transcriptional changes. Aim 2 will investigate the role
MEOX1-target regulatory elements and genes in fibroblast activation and utilize a newly developed cellular tool
to map MEOX1 occupancy and histone marks in human cardiac fibroblasts, uncovering the MEOX1-dependent
gene-regulatory networks driving fibroblast activation.
These studies will provide a definitive answer to whether MEOX1 is a central regulator of fibroblast activation
and fibrosis in heart failure, delivering vital insights into the molecular mechanisms driving fibroblast activation
and identifying potential therapeutic targets.

Public health relevance
PROJECT NARRATIVE Cardiac fibrosis, which results from fibroblast activation, is associated with unfavorable outcomes in heart failure, a very common and lethal disease. Our previous in vitro and in vivo studies identified MEOX1, an understudied transcription factor, as a key player in cardiac fibroblast activation. This research aims to determine if targeting MEOX1 in vivo can reduce cardiac fibrosis and improve heart failure outcomes in mice, while also mapping the gene networks governing fibroblast activation.